Developmental Research Project Program

Abstract
A central component of NH-INBRE is its Developmental Research Projects Program (DRPP). The DRPP
component provides 1) research opportunities and training for students; 2) professional development for
DRPP-funded Project Leaders (PLs) and students; 3) development of the research and science culture at
Partners. Through this mechanism, NH-INBRE directs resources to support the best biomedical research at
Partners through multiple mechanisms to faculty from our 7 four-year primarily undergraduate Partner
Institutions.
The DRPP aims to direct NH-INBRE resources to support the best biomedical research at Partners and
provides multiple mechanisms to support this through Pilot Project (PP), Research Project (RP) grants, and the
new Targeted Incentive Grant(TIGs) and Seed Grant program.
The DRPP develops and releases funding opportunity announcements to NH-INBRE participating institutions
that solicit research proposals from faculty members. The proposals that fit into the biomedical themes of NH-
INBRE then undergo anonymous peer review and are ranked according to perceived merit. Both scientific merit
and the ability of the project and its Principal Investigator to provide a solid research experience for
undergraduate students participating in the project are considered. Funding is awarded based on this ranking.